Movement Analysis Research Core (MOVAN)

Program Director/Principal Investigator (Last, First, Middle): STERGIOU, NICK
Project Summary
In Phase 2, the Movement Analysis Research Core (MOVAN) was established as a successful resource for
providing exceptional access to state-of-the-art measurements of behavioral function and movement analysis
for human movement variability research to treat and prevent motor-related disorders. MOVAN is a unique
resource within the state of Nebraska, allowing our MOVCENTR investigators to develop distinctive tools and
methods to enhance the effectiveness of their research. Additionally, MOVAN includes training, consultation,
and strategic planning for all investigators, especially those who do not have primary expertise in measuring
behavioral function and movement analysis. Thus, investigators are advised on best practices, experimental
design, and available cutting-edge approaches. In Phase 3, to better serve the needs of our investigators, we
plan to develop and verify new analytical methods of human movement and improve efficiency and project
management. By broadening our offerings, our goal is to enhance the uniqueness of our core and establish a
more collaborative, multidisciplinary atmosphere to address intricate issues related to human movement
variability in state-of-the-art laboratories.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page